Quality Control of Electronic Pathology (E-Path)ResultsPeriod of Performance: September 15, 2014 - September 14, 2015

LSU will assess quality and completeness of electronic pathology (E-Path) results for colorectal cancer and breast cancer. LSU will collect electronic pathology results for KRAS mutation test results from colorectal cancer case records, and will collect HER2 results from breast cancer case records. LSU will assess the completeness of these records and document compliance with recommended testing.